Examining the Role of State-level Restorative Justice Policies and their Implementation in Mental Health Disparities among Adolescent Dating Violence Girl Survivors: A Mixed Methods Study

ABSTRACT
Adolescent dating violence (ADV) is highly prevalent among girls in the US and can have devastating
consequences for mental health, including increased risk for depressive symptoms and suicidal ideation. As
such, there is a critical need for effective depression and suicide prevention strategies for ADV girl survivors.
Restorative justice (RJ) is one policy-based justice and accountability response to ADV that has the potential to
improve youth mental health disparities among ADV girl survivors. RJ allows survivors to narrate their ADV
stories and offer perpetrators an opportunity to acknowledge and remedy the harm, and engage in
rehabilitation, which supports survivor preferences and fosters healing. To our knowledge, no study has
examined whether state-level RJ policies and their implementation impact depressive symptoms or suicidal
ideation among ADV girl survivors over time and whether impacts differ by race or ethnicity. The proposed
fellowship builds on the applicant's prior background to prepare her for a career as an independent mixed
methods researcher and behavioral scientist with expertise in structural- and community-level prevention
intervention efforts for gender-based violence and its mental health consequences. The specific fellowship
goals are to: 1) deepen health policy methods and advanced multilevel and causal quantitative analysis skills,
2) develop and strengthen intersectional mixed methods skills in public health, and 3) refine academic writing
and communication skills. These goals will be accomplished through coursework and workshops, mentorship
from the sponsor team, and execution of the proposed research project including dissemination of study
findings. The specific aims of this proposed research are to: 1) examine associations between state RJ policies
with depressive symptoms and suicidal ideation among ADV girl survivors, and test the effect modification of
race/ethnicity (N=82,400), 2) among states with a RJ policy, examine associations between policy
implementation with depressive symptoms and suicidal ideation among ADV girl survivors, and test effect
modification of race/ethnicity (N=41,200), and 3) qualitatively describe perceptions of mental health and
preferences for justice and accountability among ADV girl survivors (N=30). The proposed research uses a
sequential explanatory mixed methods (QUANT -> QUAL) approach in a two-part research project. Aims 1
and 2 leverage 4 waves of population-representative data in 48 states from the 2013, 2015, 2017, and 2019
waves of the Youth Risk Behavior Surveillance System (YRBS) and data on RJ policies specific to adolescents
from a RJ legislative database. Aim 3 uses semi-structured interviews conducted with 10 white, 10 Black and
10 Hispanic ADV girl survivors to contextualize quantitative findings and identify ways to improve and tailor the
justice response for ADV girl survivors. This proposal aligns with NIMH's youth mental health disparities call by
examining how state policies impact mental health outcomes using longitudinal data, which has the potential to
inform the mental health equity and enhancement of justice practices for ADV girl survivors.

Public health relevance
PROJECT NARRATIVE An emerging body of research suggests that state-level restorative justice (RJ) policies may be linked to better mental health among survivors of adult intimate partner violence, however limited research has examined this association among adolescent girls who have experienced adolescent dating violence (ADV) and/or determined whether and how impacts differ by race/ethnicity. The proposed research uses a sequential explanatory mixed methods design, leveraging population-representative data and qualitative data collection with diverse ADV girl survivors, to assess the impact of state-level RJ policies and their implementation on depressive symptoms and suicidal ideation among ADV girl survivors over time. Research findings can inform efforts for an innovative, policy-based solution that can be easily scaled to reduce negative mental health sequelae of ADV and inform the enhancement of justice practices to promote mental health equity among ADV girl survivors.